The impact of stress-induced DNA breaks on chromatin structure, gene activity, and neuron function

PROJECT SUMMARY:
Chronic stress causes molecular adaptations and structural remodeling of neurons within corticolimbic
brain areas, including the prefrontal cortex (PFC) and hippocampus (HPC). This is important because the PFC
and HPC are integrated in brain circuits that regulate complex behaviors and cognition. Preclinical and clinical
studies indicate that synapse loss and reduced connectivity in the PFC and HPC contribute to behavioral and
cognitive symptoms in several psychiatric disorders, such as post-traumatic stress disorder (PTSD) and major
depressive disorder (MDD). While previous reports have identified candidate genes and pathways, the molecular
mechanisms that cause lasting stress-induced changes in gene activity patterns and structural remodeling in
neurons remain unknown. In preliminary studies, exposing mice to chronic unpredictable stress (CUS) triggered
the formation of DNA double strand breaks (DSBs) within stress-activated neurons in the PFC. Administration of
the GABAA receptor agonist, diazepam, diminished both the number of stress-activated neurons and the levels
of DSBs, suggesting that stress-induced DSBs are generated by activity-dependent mechanisms. Accumulating
evidence indicates that neuronal activity induces the topoisomerase, topoisomerase II (Top2B) to generate
DSBs and promote the transcription of an important subset of genes that mediate experience-driven synaptic
changes, including early response genes (ERGs), such as Fos, Npas4, Egr1, and Arc. These results suggest
that experience-dependent DSB formation could regulate stress-induced gene activity patterns and subsequent
remodeling of neurons. Yet the sites of stress-induced DSBs in PFC and HPC neurons have not been mapped
and how DSBs affect stress-related gene activity patterns has not been explored.
Interestingly, preliminary studies revealed that recurrent and ectopic induction of Top2B-mediated DSBs
in cultured neurons is sufficient to recapitulate chronic stress-induced gene expression profiles for various
neuronal activity-responsive genes, including ERGs and Bdnf. Preliminary chromosome conformation capture
(3C)-based experiments (3C and 4C-seq) further suggest that DSBs regulate gene activity patterns by altering
chromatin topology. These observations have led to the hypothesis that recurrent DSB formation during chronic
stress alters chromatin architecture at associated genes, which in turn, stabilizes stress-related gene activity
patterns that trigger neuronal remodeling and synapse loss in the PFC and HPC. To test this hypothesis, the
proposed studies will map genome-wide sites of CUS-induced DSBs and utilize conditional deletion of Top2b to
define how DSBs affect stress-dependent changes in transcription and neuronal structure and function in PFC
and HPC projection neurons. Additionally, 3C-based methods (HiChIP) will be employed to assess how DSBs
affect stress-dependent changes to chromatin architecture. Together, these efforts will provide novel insights
into the mechanisms driving stress-induced neuronal adaptations, and may uncover new therapeutic strategies
for psychiatric disorders, such as PTSD and MDD.

Public health relevance
PROJECT NARRATIVE: Chronic stress causes molecular adaptations and structural remodeling of neurons, which leads to behavioral and cognitive deficits. Our work shows that neuronal activity-induced DNA double strand breaks (DSBs), which regulate the expression of genes that mediate experience-driven synaptic changes, are also increased in stress-activated neurons. By mapping the sites that incur DSBs following chronic stress and deciphering the role of DSBs in stress-induced gene activity patterns and neuronal remodeling, this project will enhance fundamental knowledge of how stressful experiences cause lasting changes in behavior.